DISTRIBUTED LABORATORY DATA ACQUISITION AND CONTROL SYSTEM

An integrated laboratory data acquisition and processing system has been developed for LCP and LMB, NIDDK, in Building 2, NIH. the system is configured with satellites coupled through a local network to a host processor. Each satellite is a dedicated microcomputer system performing data acquisition from, and control over, an instrument/experiment. Although acquired data files may be stored locally, they are normally transferred via the network to a host storage medium. The local network allows the host storage medium to appear as a "virtual" storage device to the satellites.